Yale-SCORE Resource Support Core

RESOURCE SUPPORT CORE ABSTRACT
The main objective of the Resource Support Core is to provide essential research-related resources to Yale-
SCORE investigators, trainees, and collaborating researchers. The resources provided will serve to maximize
the quality of the data, the comparability of data across Projects, and to increase dynamic communication
among Yale-SCORE researchers to ensure the translation of results across projects and within the greater
research environment. The Core will: 1) Provide expert consultation, management, and coordination of
IRB/IACUC approvals, regulatory procedures and data safety monitoring, as required for animal and human
Projects and Pilots; 2) generate comprehensive strategies to recruit equal numbers of females and males in
samples of human subjects into all Yale-SCORE clinical studies and ensure that equal numbers of female and
male animals are studied in preclinical projects; 3) provide data management and analytical techniques that
incorporate state-of-the-art SABV approaches across the conceptualization, methods, analysis, and reporting
of all Yale-SCORE findings; 4) provide centralized training and quality control of core assessments and assays
across animal and human studies to maximize the scientific yield across studies; 5) provide expertise to mine
national and international big data sources with computational and machine learning approaches, to expand
our focus on sex differences in alcohol science across the lifespan; 6) and, provide access to large recovery
communities for research opportunities.

Public health relevance
RESOURCE SUPPORT CORE NARRATIVE The Resource Support Core is addressing public health by supporting the dramatic need for interdisciplinary and translational research to address the concerning increase in rates of alcohol-related mortality among women. The key purpose of the Resource Support Core is to provide essential research-related resources to the Yale-SCORE.